IMMUNOREGULATION BY ANTI-IDIOTYPE ANTIBODIES

The goal of this project is to characterize the mehcanisms by which anti-idiotype antibodies regulate immune responses and lymphocyte function. A system has been developed in which, for the first time, soluble antibody responses to the synthetic polypeptide (T,G)-A--L can be generated and detected in vitro using antigen-primed lymph node cells. Responses are antigen dependent and specific, and h-2 linked Ir gene regulated. Antibodies specific for the idiotypes of anti-(T,G)-A--L antibodies induce antigen-independent anti-(T,G)-A--L antibody responses. These responses are specific at the levels of the anti-idiotype reagent, the antigen-priming, and the antibody produced. The anti-idiotype antibodies stimulate function from antigen-primed T lymphocytes in the form of soluble helper lymphokines, and function from both primed and unprimed B cells in the form of specific antibody secretion. Unprimed B cells, in addition to anti-idiotype, required either primed T cells or idiotype or unrelated antibody complexes to be present in order to obtain function. Responses to anti-idiotype antiobodies, in contrast to those to antigen, appear not to be regulated by Ir genes. A monoclonal anti-idiotype wich reacts with a public idiotope present on the majority of anti-(T,G)-A--L antibodies from mice of the IgCH b haplotype e.g., B10 but absent on such antibodies from mice of the IgCH a haplotype e.g., Balb.B has been obtained. Expression of this idiotype has been assessed in anti-(T,G)-A--L responses utilizing T and B lymphocyte mixtures prepared with cells from idiotype positive and negative strains in all combinations. No evidence was obtained for an idiotype-regulating T helper lymphocyte. The monoclonal anti-idiotype in soluble form failed to stimulate anti-(T,G)-A--L responses in vitro.